Smartphone-based location tracking during adolescence

PROJECT SUMMARY/ABSTRACT
Many parents in the U.S. use smartphone applications to track where their teenagers are (“smartphone location
tracking”, or SLT). This project will be the first large-scale investigation of parent SLT use, yielding the first
descriptive data on how parents use SLT, the first longitudinal data on the impacts of SLT, and the first
examination of how SLT and its impacts vary developmental and contextual factors.
We propose to recruit 980 families with a teen in 9th, 10th, or 11th grade across the U.S, then follow them for 18
months. The sample will match Census demographics and be recruited via both nationwide online ads and local
offline recruitment strategies. Teens & parents will complete remote assessments every 3 months after study
entry. Both survey data and objective measurements of parent SLT use will be collected and longitudinally related
to indices of teen adjustment (e.g., delinquency, victimization) and family functioning (e.g., communication, trust).
Using the resulting data, we will pursue four aims: (1) characterize when, why, and how parents use SLT, (2)
estimate the impact of parent SLT use on teen adjustment and family functioning, (3) evaluate developmental
factors that may predict SLT use or moderate its impacts, and (4) identify contextual factors that may predict
SLT use or moderate its impacts.
To enhance the likelihood of success, the study team includes expertise and experience on research with
adolescent populations, developmental psychopathology, parenting, delinquency, victimization, digital
technology use among teenagers, and neighborhood and environmental contexts.
The expected outcome of the project is high-quality evidence on parent SLT use and its impacts. For parents
and clinicians, findings will provide guidance on how to use SLT effectively, minimize any negative side effects,
and maximize fit to development and context. For researchers, this project will lay the foundation for the scientific
study of a new parenting phenomenon, providing the first measurements of most SLT constructs and the first
large-scale empirical analysis.

Public health relevance
PROJECT NARRATIVE Many parents in the U.S. use smartphone applications (“apps”) to track where their teenagers are. This project will be the first large-scale, longitudinal investigation of how using these apps affects adolescent adjustment and family functioning. Findings will give parents and clinicians much-needed guidance on how to use the apps in the healthiest ways possible.